Automated Cassette-Based Radiosynthesis Equipment

Project Summary This application requests funding to support the purchase of a modernized automated PET radiochemistry cassette synthesis platform for PET radiotracer production. The system will be installed at the Vanderbilt University Institute of Imaging Science’s Radiochemistry Core (RCC) facility; a core that allows access to research radiotracers for use on three human PET/CT imaging systems, two pre-clinical PET imaging systems and a variety of other end uses. The core also offers expertise in allowing investigators to develop novel radiotracers for routine production. The RCC currently operates a GE TRACERLab MX module as the main GMP production module for a number of heavily utilized radiotracers. However, the TRACERLab MX, a 30-year-old, early-generation automated cassette radiosynthesis module with dated performance and declining health, has outlasted its projected use and both parts and service are no longer available. Thus, the proposed GE Fastlab 2 with HPLC+ was chosen to replace the existing and obsolete TRACERLab MX. Breakage of the TRACERLab MX would cause major disruptions to the core’s ability to support all ongoing NIH-funded studies that use radiotracers produced on this module. The Fastlab 2 with HPLC+ will substantially advance our radiotracer production capabilities, especially with the addition of the HPLC purification system married to a cassette-based radiosynthesis module. This upgraded capability would allow for more reliable production of some of the most requested radiotracers and allow for smooth integration of newly developed radiotracers to support ongoing future NIH-funded research. The proposed system will be placed in the radiochemistry core and used to support current and future NIH-funded research ranging from studying the molecular basis of cancer, cardiovascular, and neurological diseases to developing novel therapeutic approaches.

Public health relevance
Project Narrative This application requests funds to purchase an automated radiosynthesis platform to prepare radiopharmaceuticals for positron emission tomography (PET) imaging. Compounds, or ‘radiotracers’, prepared using this equipment will be used to non-invasively detect disease and measure response to therapies in human beings and preclinical models.